Deciphering Complement-Dependent Macrophage Phenotypes in Human Autoimmune Arthritis

Project Summary
Despite advances in the treatment of rheumatoid arthritis (RA) with biologic therapies, a substantial number of
patients do not have adequate disease control and specifically fail commonly used treatments. This suggests an
unmet need for new and personalized therapies for RA. Current studies have found that tissue macrophages in
the synovium of patients with RA can interact with complement factors, a complex innate immune system that
plays critical roles in rheumatic diseases by promoting inflammation and disrupting tissue homeostasis.
Specifically, our recent work has revealed that the MERTK+ tissue macrophages are expanded in lymphocyte-
low synovial RA tissues and display multiple complement factors, including the receptors C5AR1 and C3AR1. In
particular, we observed that a new MERTK+ macrophage subtype we refer to as the MERTK+HBEGF+ tissue
macrophage is marked by high C5AR1, TNF, and CXCL2 and CXCL3 expression. Through experimental
validation, we further found that the addition of an inhibitor of C5aR1 suppressed the inflammatory and interferon
response pathways while upregulated tissue protective phagocytic programs. Thus, we hypothesize that
modulating specific complement pathways in the MERTK+ tissue macrophages could improve homeostatic
synovial macrophage function in this apparently dysregulated subtype, and further relieve deleterious pro-
inflammatory cytokine and other mediator signals propagated by neighboring synovial fibroblasts. Herein, we
propose to determine the complement component signatures and responses for the MERTK+HBEGF+ tissue
macrophages (Aim 1), define how complement pathway crosstalk impacts synovial macrophages and fibroblasts
(Aim 2), and evaluate how macrophage phagocytic function is enhance by complement pathway modulation
(Aim 3). Together with our established synovial RA tissue cohort, developed single-cell omics integrative
methods, and ex vivo and in vivo experimental assay and macrophage-fibroblast co-cultured system in place,
these aims will provide novel insights into a new complement pathway-modulated macrophage target population
that upon rewiring may restore tissue homeostasis and suppress tissue inflammation (Significance). Our
proposed work will also generate new computational-experimental integrative methods and single-cell spatial
transcriptomic approaches that are urgently needed for translational research toward personalized treatments of
RA and other autoimmune diseases that are revealed through emerging single-cell technologies (Innovation).

Public health relevance
Project Narrative Rheumatoid arthritis (RA) affects up to 0.8-1% of the world's population, causing chronic pain and inflammation in the synovium that leads to joint destruction, disability, and a shortened life span. Patients that have a lower level of lymphocyte infiltrates in the synovium are more likely to fail anti-inflammatory disease-modifying antirheumatic drugs (DMARDS), so there is an unmet need to identify new targets and pathways for these challenging cases. Based on our observation of the expansion of MERTK+ tissue macrophages in these lymphocyte-low RA synovium, in our proposal we will study novel macrophage phenotypes and their interaction with synovial fibroblasts through modulation of specific complement activation pathways, which will provide a direct translational research route towards the identification of novel personalized treatment for patients with RA.